Using digital health to improve diet quality among adults at risk for cardiovasclar disease

ABSTRACT
Over 100 million Americans suffer from high blood pressure and thus are at increased risk for cardiovascular
disease and premature morality. Evidence supports the DASH (Dietary Approaches to Stop Hypertension)
dietary pattern to reduce blood pressure. DASH is rich in fruits and vegetables, legumes, lean protein, and low-
fat dairy, and reduced in red meats, sweets and processed foods. In the past 20 years, numerous trials have
demonstrated the blood pressure-lowering effects of DASH across a diverse range of populations. As such,
DASH is part of national dietary and blood pressure guidelines. Despite this strong evidence, fewer than 1% of
U.S. adults with high blood pressure fully meet DASH guidelines. Like most efficacious interventions, the rate-
limiting step involves dissemination. Behavioral trials testing DASH have been delivered primarily in-person, an
approach that is effective but not accessible to the broader population. Innovative and accessible strategies to
disseminate DASH, such as digital health, are critically needed. To address this need, we developed and
tested the feasibility of a 3-month digital health intervention called DASH Cloud. The DASH Cloud intervention
asked participants to track their diet daily using a commonly-used commercial tracking app with an extensive
nutrient database. Our intervention technology platform extracted food and nutrient data from the app using an
application programming interface (API). Each day, using this API software, we compared individual
participant’s nutrient intake to the recommended levels in the DASH diet. We then processed the data against
an algorithm and sent automated text messages to each participant with information on DASH diet adherence
and diet tips. Results indicated that we successfully recruited and retained individuals with elevated blood
pressure, achieved high engagement with daily diet tracking and saw positive changes in diet quality. Based
on the results of the feasibility trial, we will improve upon the personalization of the automated text messages
and include a scalable and responsive way of delivering coaching, based on diet data received in the app. The
efficacy of this approach will be tested via a fully-powered 12-month randomized controlled trial, DASH Cloud.
The trial will examine the effects of the intervention on changes in dietary quality and blood pressure among
men and women with high blood pressure, using the new blood pressure guidelines for nonpharmacological
treatment. The primary outcome is 6-month change in DASH adherence, as measured by 24-hour recalls. We
will also measure DASH adherence at 12-months post-randomization. Secondary outcomes include changes
in blood pressure and other physiological outcomes (e.g. weight, lipids, glucose). The scientific premise of this
proposal represents establishing the efficacy of a previously-deemed feasible approach for disseminating the
DASH diet. With the millions of Americans in dire need of nonpharmacological treatments for blood pressure,
the public health impact of disseminating the DASH Cloud intervention could drastically reduce the incidence of
cardiovascular disease. The findings from this study prepare us for a future implementation trial, testing the
potential to implement DASH Cloud within clinics and other healthcare institutions, yielding a wider
dissemination of this evidence-based intervention.

Public health relevance
We propose to evaluate the efficacy of an innovative approach for disseminating the DASH diet using mobile technologies. Given that now over 100 million adults need nonpharmacological treatment for blood pressure, the public health impact of disseminating the DASH Cloud intervention could drastically reduce the incidence of cardiovascular disease. Our approach will also advance the science of digital health and intervention dissemination efforts. Instead of designing our own smartphone app, we are building upon apps that tens of millions of Americans are already using and adding evidence-baed behavior change principles. We recently completed a 3-month feasibility trial testing the feasibility of the DASH Cloud intervention. Based on preliminary results of the pilot, we propose to conduct a fully-powered trial in which we will examine DASH Cloud’s efficacy to improve DASH adherence and reduce blood pressure among 300 adults in need of nonpharmacological treatment for blood pressure. The findings from this study prepare us for a future implementation trial testing the potential to implement DASH Cloud into clinics and other health care institutions to better disseminate this evidence-based intervention.